CORE--FUNCTIONAL GENOMICS CORE AT OU

The University of Oklahoma is providing support of a DNA Microarray Core Facility by funding the purchase of microarray equipment, computer hardware, and renovation of a suitable clean room environment in George Lynn Cross on the OU campus in Norman, OK. The OUD DNA Microarray Core Facility is an extension of the our Advanced Center for Genome Technology, with Bruce Roe and Tyrrell Conway as Co- directors of the AGGT. The MCF was designed with the capacity to manage multiple genome-wide expression projects. The capabilities of the MCF include target generation, microarray printing, hybridization, microarray scanning, image processing, and data analysis. The mcf WILL fully support all aspects of the E. coli O157:H7 and human image processing, and data analysis. The MCF will fully support all aspects of the E./ coli O157:H7 and human macrophage gene expression profiling projects being proposed for the OU campus in Norman. The project postdocs will bring RNA samples to the MCF and the facility personnel will hybridize the microarrays, analyze the data, and provide the data to the project postdocs and PIs. The MCR personnel will be available to train other University of Oklahoma scientists, provide support for their pilot projects, and help them to generate preliminary evidence for submission of biomedical research proposals to NIH.